Interplay between mechanical forces and retinoic acid in lung development

PROJECT SUMMARY
Breathing after birth requires coordinated development of the airway epithelium and its surrounding
mesenchyme and mesothelium. In the fetus, these tissues form in response to exogenous forces from fluid
pressure within and around the developing lungs that is normally high in the lumen of the airways, thus
generating a positive transpulmonary pressure. The mechanical environment of the fetal chest cavity is
disrupted by conditions such as congenital diaphragmatic hernia (CDH), which reduces or reverses the
pressure across the developing lungs and leads to pulmonary hypoplasia, a major cause of neonatal mortality.
Although several biochemical signals, including retinoic acid (RA), have been implicated in the pathogenesis of
CDH, the mechanical forces and signaling downstream of transpulmonary pressure that regulate lung
development are unknown. Our preliminary and published data suggest that transpulmonary pressure itself
regulates the RA-biosynthesis pathway, airway epithelial branching morphogenesis, and airway smooth
muscle differentiation. Here, we propose to take advantage of our innovative microfluidic platforms, tissue-
specific knockout mice, fluorescent reporter mice, and mouse models of CDH to uncover the molecular
mechanisms that connect pressure, RA signaling, and morphogenesis and differentiation within the embryonic
lung. We will combine these approaches with time-lapse imaging of lung explants, single-cell transcriptomic
analysis, and real-time fluorescent force sensors. In Specific Aim 1, we will test the hypothesis that pressure
activates the mechanosensor Yap in a tissue-specific manner to regulate the spatiotemporal pattern of
expression of genes involved in the RA-biosynthesis pathway. In Specific Aim 2, we will uncover the effects of
pressure and tissue-specific synthesis of RA on airway epithelial growth and morphogenesis and airway
smooth muscle differentiation. In Specific Aim 3, we will measure the relative effects of pressure and RA
signaling on tension, strain, and fluidity within the epithelium, mesenchyme, and mesothelium. This work will,
for the first time, identify the tissue-specific mechanical forces and molecular signaling downstream of
transpulmonary pressure that regulate early morphogenesis of the lung. We expect that our findings will
suggest novel therapeutic targets for the treatment of defects in lung development.

Public health relevance
RELEVANCE Breathing after birth requires coordinated development of the airways and surrounding tissues within the lung. Defects in the mechanical environment of the fetal chest cavity, such as congenital diaphragmatic hernia, disrupt the pressure across the developing lung and lead to abnormal development of the airways. Here we combine an innovative model system to mimic the mechanical environment around developing lungs with transgenic mice to measure the mechanical forces and identify the molecular signals that are activated by pressure, which will suggest new therapeutic targets for the treatment of underdeveloped lungs.